Nutrient Sensing and Hexokinases in T. brucei

DESCRIPTION (provided by applicant): Glucose metabolism is the sole source of ATP for the infectious lifecycle stage of the African trypanosome, Trypanosoma brucei. Mis-regulation of the first enzyme in the pathway, hexokinase, is toxic to the parasite. However, little is known concerning the regulatory mechanisms that modulate expression of the two genes that encode this essential enzyme activity. The goal of this application is to identify the mechanisms the parasite employs to regulate hexokinases at the gene expression and enzyme activity levels in response to distinct environmental conditions. Preliminary data indicates the trypanosome hexokinases are dynamically regulated in response to environmental glucose levels through mechanisms that include both modulation of transcript steady-state abundance and expression, as well as changes in enzyme oligomer composition. Regulation of transcript abundance in the African trypanosome occurs primarily via post-transcriptional mechanisms as a result of information encoded in gene 3'UTRs. Elements that influence hexokinase steady-state transcript abundance will be identified by monitoring transcript levels of a reporter gene construct harboring a series of mutated hexokinase 3'UTRs. The impact of these constructs on gene expression will also be considered by scoring enzyme activity of the reporter gene. At the protein level, hexokinase hexamer composition, which the parasite can alter based on growth conditions, influences enzyme activity, including sensitivity to regulatory molecules. To understand the differences in sensitivity to regulatory molecules, site-directed mutagenesis will be used to identify domains and residues required for inhibitor binding. The impact of variants that are engineered to no longer be susceptible to regulation in vitro will be assessed in vivo by expression in T. brucei. Through the characterization of regulatory mechanisms required for hexokinase expression, new means of targeting glucose metabolism, a required parasite pathway, will be identified. PUBLIC HEALTH RELEVANCE: The proposed research is important to public health as mechanisms identified here will yield new targets for desperately needed therapeutic development for the African trypanosome while expanding our understanding of the fundamental cellular process of glucose sensing, topics that are supported by the mission of the NIH.

Public health relevance
The proposed research is important to public health as mechanisms identified here will yield new targets for desperately needed therapeutic development for the African trypanosome while expanding our understanding of the fundamental cellular process of glucose sensing, topics that are supported by the mission of the NIH.